Preclinical development and validation of targeted mass spectrometry assays for serous ovarian cancer diagnosis

PROJECT SUMMARY/ABSTRACT
Ovarian cancer is the most lethal gynecologic malignancy. The majority of ovarian carcinomas are diagnosed
at an advanced stage for which the treatment options are considerably limited and the 5-year survival rate is
<30%. Despite their widespread use in the clinic, current immunoassay- and transvaginal ultrasound-based
diagnostic tests for women with ovarian cancer have had a limited impact on reducing mortality rates due to
their low sensitivity and specificity. Consequently, these methods have minimal utility to screen the general
population for ovarian cancer. Targeted mass spectrometry (MS) assays that measure ovarian cancer protein
biomarkers can fulfill a significantly unmet need in establishing sensitive and specific diagnostic biomarkers.
Serum is an ideal biological fluid within which to measure these diagnostic biomarkers due to its non-invasive
method of collection. We have identified a panel of candidate ovarian cancer protein biomarkers in patient
serum, which may serve to differentiate healthy patients versus patients with serous ovarian cancer – the most
common subtype of epithelial ovarian cancer. In the proposed work, we will develop and validate a sensitive
and specific multiplexed targeted MS assay to quantify 9 of these diagnostic serous ovarian cancer protein
biomarkers in serum. This will be accomplished using Parallel Reaction Monitoring (PRM) MS, which is a
highly sensitive, selective and specific targeted MS method with a wide dynamic range and low limits of
quantification, enabling streamlined method development and robust, multiplexed protein quantification. We
will evaluate the analytical and clinical performance of our multiplexed PRM assay in measuring these
prioritized biomarker candidates using a panel of >1,300 serum samples obtained from a geographically
diverse cohort of women receiving gynecologic care at five cancer centers and academic health centers in the
U.S. and one in Europe. Our multidisciplinary investigative team brings together researchers with diverse
expertise in analytical chemistry, clinical chemistry, ovarian cancer biology, epidemiology, and biostatistics.
The successful completion of the high impact pre-clinical studies described in this proposal will enable the
differentiation of serous ovarian cancer patients from healthy patients based on the abundance of diagnostic
serum protein biomarkers. This work will provide a foundation for the development and validation of novel
multiplexed PRM assays that could readily be applied to other ovarian cancer patient cohorts to support
diagnosis and early detection efforts.

Public health relevance
PUBLIC HEALTH RELEVANCE Current clinical tests for women with vague symptoms of ovarian cancer, or women who are at high risk for ovarian cancer, include measuring serum CA-125 levels by antibody-based approaches and performing transvaginal ultrasound. However, these methods are not adequately sensitive or specific to screen the general population. The goal of this application is to develop a novel mass spectrometry-based assay to measure a panel of proteins in serum to serve as diagnostic biomarkers for serous epithelial ovarian tumors, which are the most common sub-type of ovarian cancer.